Vessel Identification and Tracing in DSA Image Series for Cerebrovascular Surgical Planning

Project Summary
Although Digital Subtraction Angiography (DSA) is the most important imaging for visualizing cerebrovascular
anatomy, its interpretation by clinicians remains difﬁcult. This is particularly true when treating arteriovenous
malformations (AVMs), where veins and arteries are entangled and need to be carefully identiﬁed. The presented
project aims at enhancing DSA image series to remove this difﬁculty. Our long-term goal is to contribute toward
the development of intuitive and interpretable visualization tools to improve the diagnosis, planning and treatement
of neurovascular pathologies. Our overall objectives in this project are to (i) develop a new method, based on
machine learning, to localize the AVM and distinguish between veins and arteries surrounding it in DSA image
series, and (ii) develop an algorithm that classiﬁes arteries as terminal, en passage or bystanders. In addition
to examine the impact of our approach in planning neurovascular surgeries through a retrospective study. The
rationale for this project is that such technology will likely enhance DSA imaging and provide an interpretable tool
to clinicians that will facilitate planning cerebral AVM procedures, and furthermore, provide a decision support
tool that can be used during surgery to help review and correlate the anatomic ﬁndings seen in the surgical ﬁeld
to the preoperative angiogram. To attain the overall objectives, the following two speciﬁc aims will be pursued:
(1) develop an image processing algorithm for AVM localisation and artery/vein classiﬁcation and (2) develop an
algorithm that can identify arteries as terminal, en passage or bystanders. Under the ﬁrst aim, we will test our
working hypothesis to show that it is possible to localize an AVM in DSA image series and to distinguish between
feeding arteries and draining veins surrounding or creating the entanglement, using deep neural networks to
outline the shape of the AVM in the images and independent component analysis to understand blood ﬂow
disruption. For the second aim, we will establish a set of rules to classify arteries contributing or not to the AVM
and implement these rules into a dynamic instance segmentation algorithm that will trace vessels individually,
in a DSA image series. This algorithm with rely on a foreground/background subtraction to genrate a vascular
graph and on deep neural network to classify vascular junctions to produce an instanciated graph. Using this
graph and the pre-deﬁned rules it will be possible to visually distinguish between the different artery patterns.
The proposed project is innovative because it will be possible to automatically distinguish veins from arteries and
classify arteries as terminal, en passage, or bystander in a DSA image series without altering standard clinical
routines. The proposed project is signiﬁcant because it will enhance DSA imaging with an intuitive visualization
allowing clinicians to better understand AVM-induced vessel entanglement in order to preserve vessels from being
mistakenly clamped during surgery, thus avoiding intraoperative hemorrhaging or postsurgical deﬁcits. These
results are expected to have an important positive impact because they will ultimately provide new opportunities
for the development of novel planning techniques to improve the treatment of neurovascular malformations.

Public health relevance
Project Narrative The proposed research is relevant to public health because it focuses on developing a new technology to better interpret and understand neurovascular imaging. Once developed there is the potential for significant advances in diagnosis, surgical planning and treatment of cerebrovascular malformations. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to creating biomedical technologies to improve health.